Project: Epigenetics, Polygenic Risk and the Social Environment in Autism

ABSTRACT: RESEARCH PROJECT
Intellectual and developmental disabilities (IDD) affect up to one in six children in the United States, with
proposed etiologies ranging from genetic to multi-factorial. For a vast majority of children, no clear genetic or
environmental etiology is identified, although evidence suggests that genetic (intrinsic) risk may interact with
the early learning and social environment (extrinsic risk) to predict neurodevelopmental outcomes in later
stages of life. For example, the neuropeptide oxytocin and its receptor (OXTR) are epigenetically altered by
early social experience, play crucial roles in mammalian social and cognitive development, and are associated
with both genetic and epigenetic risk for autism spectrum disorder (ASD). The objective of this Hawk-IDDRC
Research Project is to examine epigenetic, polygenic and environmental risk factors for IDD, focusing on ASD
as a prototype. We will use an innovative new smartphone application, BabySteps, to enroll and collect data on
300 mothers and their children between 2 and 3 years of age, over a 6-month period. One hundred and sixty
ASD children will be enrolled, along with 80 children with non-ASD developmental delay (DD), and 80 typically
developing (TD) control children, matched by race/ethnicity, sex and family socioeconomic status. We will
examine changes in DNA methylation (DNAm) in 27 specific ASD-associated loci, as well as 3 OXTR loci, as a
function of age and social experience, in children with and without autism, comparing DNAm from stored
newborn dried blood spots to samples collected at the time of diagnosis. Polygenic risk scores for ASD will be
calculated using Illumina PsychArray, and the relative polygenic and epigenetic risk assessed using resources
from the Developmental Genomics/Epigenetics Core. The relationship between DNAm and social
experience will be assessed using 2 complementary measures: 1) the Language Experience Analysis (LENA)
based on audio recordings from a LENA device worn by the child over a 4-day period at home and in daycare;
and 2) ecological momentary assessments (EMAs) of parental social and emotional availability collected using
the BabySteps app. Children will be recruited through the Clinical Translational Core and Autism Center after
ASD is either confirmed or excluded, based on ADOS testing and/or rigorous clinical assessment. A subset of
20 ASD and 20 TD children will participate in pilot resting state functional connectivity scanning through the
Neurocircuitry and Behavior Core, to examine associations between DNAm of ASD-associated loci,
including OXTR, and differences in brain connectivity. With the Administrative Core, we will share the
BabySteps app with other Centers in the IDDRC Network and prospectively compare the effects of perinatal
stress and social/learning experience on DNAm in children yet to be diagnosed with ASD. It is hypothesized
that both polygenic factors and early social experience (via epigenetic modifications) contribute to ASD or IDD
risk. Understanding how the environment interacts with genetic vulnerability will provide an unprecedented
opportunity to re-assess early intervention and prevention strategies.